Cardiac ryanodine receptor and oxidative stress

PROJECT SUMMARY
Abnormal activity of the cardiac ryanodine receptor (RyR2) leads to increased and untimely release of Ca2+ from
the sarcoplasmic reticulum (SR), driving Ca2+-dependent arrhythmogenesis that can lead to sudden death in
many cardiac disorders. Oxidative modification of RyR2 by reactive oxygen species (ROS) has long been
established to enhance the sensitivity of the channels to Ca2+ within the SR (intraluminal Ca2+) in the failing heart.
However, both the intracellular source of ROS, as well as the specific redox-sensitive residues of RyR2 which
control intraluminal Ca2+ sensitivity, remain elusive. Our initial studies implicate the role of the SR oxidoreductase
system in this control, whereby molecular chaperones and enzymes that facilitate protein folding also modulate
activity of RyR2. We have identified intraluminal cysteines of RyR2 that elicit functional effects on the channel,
as well as an oxidoreductase chaperone that associates with the channel in a redox-dependent manner.
Moreover, we found upregulation of oxidoreductase enzyme in rodent models of cardiac disease, and observed
RyR2 activity stabilization with pharmacological inhibition of this enzyme. We therefore hypothesize that
dysregulation of the SR oxidoreductase system impairs luminal Ca2+ regulation of RyR2 via an ‘intraluminal SR
redox sensor’ and promotes arrhythmogenesis. We will test our hypothesis by 1) defining the molecular
components of the SR redox sensor that control luminal Ca2+ sensitivity of RyR2, and 2) determining the role of
dysregulated SR redox homeostasis in Ca2+-dependent arrhythmogenesis. To address these aims, we will
employ a multilevel experimental approach, investigating at the molecular, cellular, and whole heart level. We
propose to use heterologous systems, biochemical approaches and human induced pluripotent stem cell
cardiomyocyte (hiPSC-CM) technology to identify the RyR2 redox sensor. We also propose to study disease-
associated perturbations of the SR oxidoreductase system in rodent models of inherited and acquired Ca2+-
dependent arrhythmia, utilizing novel genetic biosensors, as well as adenoviral (AV) and adeno-associated viral
(AAV) gain- and loss- of function approaches. With renowned experts in cardiac EC coupling, protein
biochemistry and hiPSC-CM technology, The Ohio State University offers an exceptional training environment
for the mentored phase of the award to reach these goals. Furthermore, building on my strong background in
molecular biology, I will collaborate with an expert in CRISPR-mediated gene editing of hiPSC-CMs to study
these mechanisms in a relevant human model. The achievement of the proposed aims will uncover novel
regulatory mechanisms of RyR2 regulation, with potential to be therapeutically exploited. This proposal therefore
addresses a fruitful and unexplored research area, relevant to a spectrum of cardiovascular diseases, which will
lay strong foundations for an independent research career in cardiovascular physiology.

Public health relevance
NARRATIVE Cardiovascular disease remains an enormous health burden in the United States. Abnormal Ca2+ release in the diseased heart is closely coupled to increased oxidative stress, yet clinical trials aimed to reduce this stress have largely failed to elicit any functional benefits on cardiac Ca2+ handling. This proposal will uncover new molecular mechanisms that link oxidative stress to the regulation of Ca2+ release, and provide insights into new therapeutic approaches to reduce Ca2+-dependent arrhythmias.